Admin Core (with Enrichment Program)

The Administrative Core of the Diabetes Research Center at the University of Washington works with the
Center’s leadership, committees, and staff to oversee the operations of the four biomedical research cores,
Pilot and Feasibility (P&F) Program and Enrichment Program. The Core is responsible for the following
functions that are integral to the successful functioning of the Center: (1) Overseeing all financial aspects and
personnel matters; (2) Coordinating and managing the P&F and Enrichment Programs; (3) Managing Center
related correspondence and communications, including progress reports to NIDDK and required information to
the University of Washington; (4) Managing the Center’s website; (5) Performing periodic evaluations of
ongoing Center activities, functions and services; and (6) Planning future Center activities, including partnering
with centers and organizations at the University of Washington as well as others that are in and outside
Seattle. By performing these functions, the Administrative Core supports the Center in its mission to enhance
research, education and training in diabetes, obesity, and related disorders at the University of Washington
and in the Greater Seattle area.